Redox and Proteomic Stress Responses in Biliary Disease

PROJECT SUMMARY
Diseases of the biliary system comprise a significant percentage of the indications for liver transplantation in
adult and pediatric populations. The pathogenesis of these disorders likely involves cellular responses to the
harmful effects of bile, to which epithelial cells lining the bile ducts are continuously exposed. Bile toxicity arises
largely from the oxidative damage caused by bile salts, whose detergent properties disrupt intracellular
organelles, particularly mitochondria. Bile duct epithelial cells, also known as cholangiocytes, have evolved
strategies for preventing bile toxicity in addition to having robust anti-oxidant defense systems, which are present
in all cells to combat reactive oxygen species generated during normal metabolism.
Work from my laboratory using the zebrafish system has identified regional susceptibilities of cholangiocytes to
redox stress imparted by the plant toxin biliatresone, whose consumption is associated with epidemic biliary
atresia (BA) in livestock. Our most recent studies indicate a comparable role for regional variantion in heat shock
mediated proteostasis in cholangiocytes exposed to biliatresone, and that these responses can be modified by
the activation of cGMP signaling. Importantly, there is compelling clinical data indicating the modulation of stress
responses contributes to risk and outcomes in human BA, thus validating the biliatresone models we employ.
The goal of this proposal is to study the mechanisms responsible for the variation in cholangiocyte stress
responses using zebrafish, mouse and human cell culture models. In Aim 1, we will characterize the molecular
determinants of the redox stress response in zebrafish intra-hepatic and extra-hepatic cholangiocytes, determine
whether variation in these responses evolve from epigenetic factors that arise during biliary development, and
correlate these findings with mammalian cholangiocyte biology using mouse models. In Aim 2, we will identify
the cellular targets responsible for biliatresone-induced injury and stress in mammalian cholangiocytes using two
approaches; first, via pull-down experiments using photo-activatable biliatresone analog; second, by conducting
a genome-wide CRISPR positive selection screen for genes required for biliatresone toxicity. In Aim 3, we will
explore links between cGMP signaling and proteostasis and how this affects susceptibility of cholangiocyte to
injury using three approaches: first, by defining the downstream regulators of cGMP signaling that mediate its
inhibition of biliatresone toxicity, second, by correlating these data with a comprehensive analysis of the
cholangiocyte proteome, and how it is modified by biliatresone and cGMP signaling, third, defining the sub-
cellular domains of cGMP signaling activity and its downstream mediators.

Public health relevance
PROJECT NARRATIVE Diseases of the bile ducts are an important cause of liver failure in the adult and pediatric populations. We have discovered differences in the way bile duct cells respond to environmental stress and will examine the underlying causes and their relevance to human biliary diseases.